CARCINOGENESIS IN TGF-BETA COMPROMISED TRANSGENIC MOUSE MODELS

Transforming growth factors-beta (TGF-betas) are potent inhibitors of epithelial cell growth and have been implicated in epithelial homeostasis. Loss of responsiveness to TGF-beta has been observed in a variety of malignant cells. In several examples of human malignancies, like some retinoblastoma, liver, gastric, and certain breast and colon cancers, expression of TGF-beta type II receptors (TbetaRII) is either greatly decreased or absent, implicating loss of TbetaRII function as one mechanism contributing to tumor development. We have demonstrated that epithelial cell lines, in which a truncated, signaling-deficient TbetaRII receptor (TbetaRIItr) is overexpressed by stable transfection, lose anti-proliferative and matrix-inducing responses to TGF-beta. To achieve this dominant-negative mutant effect resulting in abrogation of TGF-beta signal transduction in specific epithelia in whole animals, we have generated transgenic mice in which the TbetaRIItr was overexpressed utilizing tissue-specific promoters. High levels of TbetaRIItr expression have been achieved in liver, intestinal and pancreatic epithelia in 2 transgenic lines using a metallothionein promoter, and in mammary gland epithelia in 3 transgenic lines using the mouse mammary tumor virus (MMTV) long terminal repeat (LTR) promoter/enhancer. Biological responses to TGF-beta isoforms 1, 2 and 3 are lost in primary hepatocyte cultures generated from metallothionein/ TbetaRIItr transgenic mice. These dominant-negative TbetaRII transgenic mouse models, as well as mice in which the TGF-beta1 gene is deleted from one allele by homologous recombination, resulting in 50% decrease in TGF-beta1 protein levels in all tissues, should provide clinically useful insights into the physiological functions of this cytokine system during tumor initiation, promotion and progression, and illuminate how it could be most effectively utilized as mediator in chemopreventive strategies.